Chemical exposure disruption of the placental circadian clock

ABSTRACT
Adverse reproductive outcomes, including preeclampsia and hypertension, preterm birth, growth restriction, and
small for gestational age birth contribute significantly to maternal and infant morbidity and mortality and can lead
to long term health consequences for both mother and offspring. The placenta plays a central role in successful
pregnancy outcomes, fetal development, and it is increasingly being recognized for playing an important role in
developmental programming of the fetus and contributing to childhood health and disease. Environmental
chemicals are known to contribute to the risk for adverse reproductive outcomes and these chemicals may be
eliciting their toxic effects through impacts on the function of the placenta. One particular function of the placenta
that is only beginning to be fully understood is its role as a peripheral molecular clock. Disruptions to the
molecular clock are recognized to be involved in several adverse reproductive outcomes and recent data
suggests that deregulation of molecular clock genes impacts important placental cellular processes such as cell
migration. There is also evidence to suggest that the epidermal growth factor (EGF) maybe a central regulator
of the placental molecular clock and that a mixture of toxic chemicals, including pesticides, alters the placental
molecular clock through inhibition of EGF signaling through the EGF receptor (EGFR). These findings support
the premise that a properly functioning molecular clock is required for placental health. However, it remains
unknown if environmental chemicals cause placental dysfunction via molecular clock disruption. This
consortium, consisting of a placental toxicologist (Veiga-Lopez), circadian biologist (Hoffmann), and pregnancy
molecular epidemiologist (Marsit), has developed a project that will lead to an understanding of how gestational
environmental exposures impact the molecular clock resulting in placental dysfunction, by examining the overall
hypothesis that chemicals that interfere with molecular clock signaling through EGFR lead to placental cell
dysfunction in a gestational age- and placenta layer-specific manner. In a mouse model, we will examine how
gestational age, placenta layer, and sex impacts molecular clock sensitivity to chemical exposures. In human
placenta cellular models, we will identify mechanisms through which the molecular clock proteins PER1, PER2,
and PER3 impact cellular function upon chemical exposures. Finally, using a pregnancy cohort of farm-working
women and their offspring, we will determine the association between pesticide exposure and placental
molecular clock gene dysregulation and build causal evidence by comparing results to those from the mouse
model. Through this new and exciting collaboration, there is a unique opportunity to comprehensively
demonstrate the importance of the placenta as a peripheral clock and to provide evidence that exposures
relevant to the human population impact the placental molecular clock which has lifelong implications for health
and disease.

Public health relevance
NARRATIVE Dysregulation of molecular clock function in the placenta is a novel mechanism causing poor pregnancy outcomes, leading to lifelong health consequences for the newborn. This transdisciplinary project proposes a new, high impact virtual consortium that will advance fundamental knowledge into chemically-induced dysregulation of the molecular clock in the placenta. This work will transform our understanding of pregnancy disorders stemming from environmental exposures and set the basis for targeting preventive approaches related to the molecular clock.